MONOCLONAL ANTIBODIES IN PREVENTION OF GRAFTUS HOST DISEASE

This protocol studies the reconstitution of the immune response after marrow transplantation in patients who receive who receive marrow which is purged of T cells with monoclonal antibodies. They are compared to patients who receive unpurged marrows.